Programmable peptide-guided protein degradation

Summary
Over 600 human proteins have been recently prioritized as key cancer targets, with nearly half being
considered ‘intractable’ by standard small-molecule inhibition approaches, due to target instability and active
site accessibility constraints. By redirecting the ubiquitin-proteasomal pathway (UPS) for targeted protein
degradation, the proteolysis-targeting chimera (PROTAC) technology provides a potential solution, enabling
rapid and continuous target consumption as well as the stronger pharmacological effects than small molecule
inhibition. Nonetheless, PROTACs suffer from similar developmental hurdles as small molecules and cannot be
easily designed for motif or post-translational modification-specific targeting. To address these hurdles,
research efforts have shifted toward gene therapy approaches by introducing the concept of protein-mediated
protein degradation. Here, E3 ubiquitin ligases are redirected by replacing their natural substrate binding
domains with “off-the-shelf” binding domains, including nanobodies, antibodies, and DARPins, to generate
target-specific ubiquibodies. To augment this platform, we recently exploited natural protein-protein interaction
information to develop algorithmic pipelines that prioritize target-selective peptides which can be fused to the
E3 ubiquitin ligase conjugation domains to induce target protein degradation. In this project, we will augment
our current methods to enable the development of these ubiquibodies (uAbs) for any protein, including those
deemed ‘intractable’ by small molecule-based means. To do this, we will automate a bipartite algorithmic
pipeline that leverages recent advancements in protein language modeling as well as existing co-complex
databases to design peptide binders to diverse protein targets, including those with solved co-crystals as well
as those with minimal structural information. Specifically, our pipeline will take user-specified target proteins as
inputs, and generate prioritized lists of candidate peptide binders as outputs, enabling subsequent generation
of uAbs for target degradation. Through library-on-library fluorescence-based assays in human cells and
subsequent encapsulation of uAb mRNA in lipid nanoparticles (LNPs), we will develop a scalable method to
test and translate our degraders for downstream in vivo validation. In total, this work will generate a robust
peptide design tool that will enhance targeted protein degradation efforts and lay the foundation for
programmable proteome editing.

Public health relevance
Project Narrative Targeted protein degradation represents a novel therapeutic strategy, enabling proteasomal degradation of pathogenic proteins. This project aims to integrate structure-based modeling, language models, fluorescent screening, and state-of-the-art gene delivery to develop a translatable peptide-guided protein degradation platform. By integrating computational and experimental methodologies, the proposed work will establish a foundational tool to design a peptide-guided degrader to any pathogenic protein of interest, enabling programmable proteome editing for broad-ranging research and therapeutic applications.